Administrative Supplement for Flow Quench Instrument

Summary/Abstract
The mechanism by which transcription factors assemble active transcription complexes on specific DNA
sequences does not appear to follow a simple recognition code. Subtle, and not-so-subtle, structural changes
occur when DNA binds to transcription factors. Our overall hypothesis is that transcription factor-DNA binding
would instead be better described by similar principles as have been elucidated for the protein folding problem.
We have discovered that the 230 amino acid intrinsically disordered transcription activation domain (TAD) of
NFκB dramatically alters its DNA binding specificity. Because the domain is disordered, we need to measure its
dynamic changes on the millisecond timescale. The best way we know to do this is by Flow Quench coupled to
HDX-MS. We are therefore requesting an equipment supplement to purchase the Flow Quench instrument. This
instrument is expected to reveal subtle changes in the ensemble population of the TAD upon DNA binding to the
DNA-binding domain that had been thought to be decoupled from the TAD. This will be critical to Aim 1 of the
parent R01. We will also use the instrument to determine subtle changes in the TAD upon ternary complex
formation with DNA and RPS3, the transcription co-activator studied in Aim 3. The HDX-MS results will inform
the computational simulations integrated with experiments in the parent grant.

Public health relevance
Transcription factors control the expression of genes, but much remains to be understood about how they work. The stress-response nuclear factor κB (NFκB) transcription factor family regulates inflammatory and responses as well as viral infections. NFκB has a large intrinsically disordered transcription activation domain and to study the dynamics of this domain we need to measure amide exchange in the millisecond time regime using Flow Quench.